Midwest AViDD Center

Overall – Midwest AViDD Center
ABSTRACT
The Midwest Anti-Viral Drug Development (AViDD) Center was formalized as a direct response to NIAID
U19 RFA RFA-AI-21-050 “Emergency Awards: AViDD Centers for Pathogens of Pandemic Concern”. The Co-
PIs of the Midwest AViDD Center are Reuben Harris and Fang Li, who have deep experience in functional and
structural virology, respectively, and in leading multidisciplinary teams to successful outcomes. The majority of
our center investigators were already working together in various capacities when this RFA was announced, and
the RFA catalyzed the nucleation of our comprehensive multidisciplinary center focused on innovative antiviral
drug development. The primary target of the Midwest AViDD Center is SARS-CoV-2 (SARS2), with all five
Projects targeting essential viral processes (two for cell entry and projects for proteolytic cleavage, nucleolytic
digestion, and RNA helicase activity). We purposely selected a balance of well-established antiviral drug targets
(entry, protease), as well as less conventional targets with equally promising long-term potential (nuclease,
helicase). All five Projects require integrated and highly collaborative support from five distinct service Cores for
administration, screening, chemistry, structural and computational biology, and virology. A major strength of the
Midwest AViDD Center is a 3-pronged screening approach [ultra-High Throughput Screening (uHTS), DNA-
Encoded Chemistry Technology (DEC-Tec), and Virtual Screening (VS)] to maximize chemical space and obtain
favorable starting points for antiviral drug development. Each Project will also pursue inhibitors of the same
assigned target for an additional RNA virus of pandemic potential – the arenaviruses Lassa virus (LASV) and
Machupo virus (MACV), the filovirus Ebola virus (EBOV), and the flavivirus Zika virus (ZIKV). Each Project
therefore has a built-in capacity to assess inhibitor specificity throughout the course of drug development. Thus,
the overall activities of the Midwest AViDD Center are organized into two specific aims. The first aim is dedicated
to research and development, where our five Projects and five Cores leverage a combination of established
and innovative approaches to develop novel, high potency, and orally available inhibitors of essential viral
proteins required for pathogenesis of SARS2 and the other viruses with pandemic potential. The second is
dedicated to interdisciplinary training, education, and outreach. Interdisciplinary training is vital for both
addressing the current COVID-19 pandemic as well as for preparing for the next one. Education and outreach
are also essential to achieve immediate and long-term impacts. Major deliverables will therefore be novel antiviral
lead compounds for further development by industry partners and, equally important, a well-trained group of
antiviral researchers including next generation experts and leaders. Both deliverables will have lasting, long-term
impacts, hopefully contributing to ending the current pandemic and becoming better prepared for future viral
outbreaks and stopping them before reaching pandemic levels.

Public health relevance
Overall – Midwest AViDD Center NARRATIVE The Midwest AViDD Center is comprised of a highly experienced, integrated, and multidisciplinary team with the common goal of developing inhibitors of SARS-CoV-2 and other viruses of pandemic concern. We utilize a balance of innovative and proven approaches and technologies to develop inhibitors to established druggable processes (viral entry and proteolytic cleavage) as well as less conventional but equally essential viral processes (nuclease and helicase activities). We aim to deliver novel inhibitors that can be developed into effective orally available drugs that potently and safely suppress virus replication and help prevent infections as well as adverse clinical outcomes including death.